Project 1:Investigations into Residual Function Following Unilateral Hearing Loss

Project Summary
Hearing loss can be a congenital or acquired condition, either a conductive or a sensorineural
variety of loss and bilateral or unilateral. Unilateral hearing loss is the more common condition.
Congenital unilateral hearing loss occurs in 1 out of 1,000 births. Unilateral conductive hearing of
all etiologies occurs in ~30 million adults. Importantly, balance impairment and unilateral hearing
loss are often comorbidities, increasing fall risk and associated hospitalization and death of the
aging population. However, unilateral hearing loss and its effects on residual hearing and balance,
is relatively understudied. When investigated, results have often not been in agreement between
studies, perhaps generated by differences in experimental protocols employed. Thus, significant
gaps in knowledge exist regarding whether: 1) neural processing in the contralesional inner ear,
most often assumed to be normal, is actually physiologically compromised: 2) whether different
modes of loss (full sensorineural versus conductive (partial) loss) result in different outcomes for
the contralateral end organs; and 3) whether either full sensorineural or conductive hearing loss
induces synaptic plasticity events along the auditory and /or vestibular central pathways that could
potentially result in dysfunctional processing, sensory mapping, etc. Such data will be important
for future investigations into whether there exists drug targets whose manipulation might affect a
better hearing/balance outcome. We will pursue three main aims to investigate these issues. In
Aim 1 we will test the hypothesis that unilateral sensorineural hearing loss and conductive hearing
loss alter the physiology of the remaining intact inner ear(s). We will assess physiology (ABRs
and single fiber electrophysiology) of the remaining cochlea following induction of both varieties
of hearing loss. Further, we will evaluate vestibular function by recording vestibulo-ocular reflexes
in mice with conductive hearing loss. In Aim 2, we will test the hypothesis that unilateral
sensorineural hearing loss and conductive hearing loss induce inflammation in the remaining
intact inner ear, suggesting mechanisms by which pathophysiological outcomes occur. Finally, in
Aim 3 we will test the hypothesis that unilateral sensorineural hearing loss and conductive hearing
loss alter synaptic plasticity within target nuclei along the central auditory and vestibular pathways.
We will examine known contributors to both physiological and structural plasticity. At the
conclusion of these studies, we will have more completely defined the effects of unilateral inner
ear dysfunction on residual hearing and vestibular systems. Such data will be important for future
strategies designed to help patients with this common condition.